Targeting tumor-specific epitope for imaging and therapy for mesothelioma

Abstract:
Malignant mesothelioma is a devastating disease without effective therapy. Among the three major subtypes,
epithelioid, sarcomatoid, and mixed (biphasic), the sarcomatoid subtype is the most difficult-to-treat. Alpha
emitting radionuclide in the form of radioimmunotherapy (RIT) has shown promising results in several cancers
due to high potency in tumor killing and low toxicity to neighboring organs/tissues. We aim to develop and
evaluate a 203Pb/212Pb isotope pair based SPECT imaging and targeted alpha therapy as precision therapeutic
tools for mesothelioma. We propose to target a tumor selective CD46 epitope that we found recently to be highly
expressed in all three major subtypes of mesothelioma. This differentiates CD46 from mesothelin that is
expressed mainly in the epithelioid but not the sarcomatous subtype. We will build our work on a novel human
monoclonal antibody that we discovered that binds to the tumor selective epitope. The antibody has been
manufactured under cGMP. An antibody-drug conjugate based on this antibody has entered clinical studies for
prostate cancer and multiple myeloma and has shown an excellent safety profile in clinical trials. We have
generated preliminary data that are directly relevant to this proposal: (1) We found that this antibody is
internalized rapidly by both epithelioid and sacromatous mesothelioma cell lines. (2) We labeled the antibody
with 89Zr and showed that it specifically detects by PET mesothelioma in xenograft models. (3) We developed a
robust and reproducible 212Pb radiolabeling process that is scalable for clinical use, facilitating translation. We
hypothesize that targeting CD46 using our clinical stage human monoclonal antibody for SPECT imaging and
alpha particle therapy will lead to the development of new treatments against mesothelioma especially for the
biphasic and sarcomatous subtypes, addressing a dire clinical need. We will evaluate 203Pb-labeled antibody for
SPECT imaging and study the 212Pb-labeled antibody in both mesothelioma cell-line and patient-derived
xenograft models to determine dosing scheme, therapeutic efficacy and tolerability. The proposed study has a
high potential of translation to the clinic and differentiates by targeting a new tumor selective epitope with rapid
internalization and increased subtype coverage. If successfully carried out, our work will lead to future clinical
trials where 203Pb-based SPECT is used for patient selection and dosimetry and 212Pb-based RIT is used to treat
mesothelioma patients across subtypes.

Public health relevance
Project narrative: We propose to develop a novel SPECT imaging and a targeted alpha therapeutic for mesothelioma treatment. We have discovered an internalizing human monoclonal antibody binding to a tumor selective epitope expressed by all three subtypes of mesothelioma. We will label this antibody with 203Pb for SPECT imaging and the highly lethal alpha particle 212Pb for therapy development.